Medical Imaging with Deep Learning (MIDL) Conference 2025

The Medical Imaging with Deep Learning (MIDL) conference is an annual event dedicated to advancing research and innovation in medical imaging, image analysis, and the development and integration of deep learning, machine learning (ML), and AI. The scope of MIDL encompasses deep learning approaches to all medical image analysis challenges, offering a platform to explore theoretical advancements and their translational applications. By fostering interdisciplinary collaboration, MIDL addresses complex problems in healthcare and biomedical sciences. NIH funding will support registration awards for students in US based institutions to attend MIDL 2025. This initiative aims to promote access to networking, mentorship, and professional opportunities in medical imaging and AI community. Recipients will be selected based on their scientific qualifications, ensuring the awards recognize and support promising researchers.

Public health relevance
The Medical Imaging with Deep Learning (MIDL) conference is an annual event dedicated to advancing research and innovation in medical imaging, image analysis, and the development and integration of deep learning, machine learning, and AI. MIDL plays an important role in workforce development of researchers working at the intersection of health care and AI. We are seeking NIH funding to support registration awards for students studying in US based institutions to attend MIDL 2025 in Salt Lake City, UT.